Logistics Core

Summary (Logistic Core)
The Logistics Core of the Indiana University-Ohio State University Maternal and Pediatric Precision in
Therapeutics Data, Model, Knowledge, and Research Coordination Center (IU-OSU MPRINT DMKRCC) will
provide overall logistic support and administrative coordination of the MPRINT Hub, including the DMKRCC and
Centers for Excellence in Therapeutics (CETs). The Logistics Core will facilitate interactions among MPRINT
Hub members, the Steering Committee (SC), and MPRINT Hub partners to promote and support multi-
disciplinary research efforts in maternal and pediatric therapeutics. The following aims will be carried out by the
Logistics Core: Aim 1, Work with the MPRINT SC and CETs to evaluate, prioritize and coordinate research
activities, data integration, knowledgebase development, pharmacometrics modeling, clinical trial design, and
outreach and education activities in the MPRINT DMKRCC. Aim 2, Coordinate the MPRINT KRCC research
activities related to knowledgebase and portal development, pharmacometrics modeling and clinical trial study
design, and out-reach and educational activities. Aim 3, Solicit, review, select and manage awards from the
MPRINT opportunity pool funds. The Logistics Core will work with the MPRINT SC to establish scope and format
for applications. The Logistics Core will work with NICHD staff to coordinate regular virtual meetings and annual
in-person meetings of MPRINT Hub. It will also work with the MPRINT SC to set research priorities, timelines,
and deliverables, and assess on-going activities of the MPRINT Hub in order to advance research and knowledge
in maternal and pediatric therapeutics.